Methodology Issues in a Tailored Light Treatment for Persons with Dementia

Project Summary/Abstract
This study's principal hypothesis is that delivering a circadian-effective, tailored lighting intervention (TLI)
will reveal a strong association between dose (amount and duration) and improvement in outcome measures
of sleep, behavior, and mood among people with Alzheimer's disease (AD) and related dementias (ADRD),
with greater responses being associated with greater doses. It is also hypothesized that a longer morning TLI
exposure (e.g., 4 h) will be more effective for improving theses outcomes, and that an all-day TLI exposure will
result in later bedtimes and greater sleep onset latency. It is further hypothesized that long-term exposure to
the TLI will promote better sleep, improved cognition, and reduced depression and agitation compared to
control lighting intervention. Preliminary results from an ongoing study of a TLI delivering a fixed amount of
circadian stimulus (CS) have demonstrated significant improvements in sleep and behavior in AD/ADRD
patients, over both the short (4 weeks) and the long (4 months) term. Elucidating the relationship between the
TLI's dose and the study's outcomes will further contribute to the scientific understanding of AD/ADRD
while providing a translational component for the development of new lighting products designed to promote
sleep and reduce behavioral disturbances in AD/ADRD patients.
The study's aims are 3-fold and involve AD/ADRD patients living in controlled environments (memory care,
nursing homes, long-term care), examining the TLI's effects on measures of sleep, behavior, and mood. First, a
randomized, within-subjects, placebo-controlled study involving 135 participants will investigate the effects of
3 TLI doses, 1 h/day, for 3 consecutive 4-week periods (with 2 intervening 4-week washouts). A second
randomized, mixed design, placebo-controlled study involving 135 participants will investigate the effects of a
fixed-CS TLI (same as in the ongoing study) of 3 durations (2 h in the morning, 4 h in the morning, and all day)
for 2 consecutive 4-week periods (with 1 intervening 4-week washout). A non-active lighting intervention will
be used as placebo control for each of the 3 active TLI conditions. A third single-arm, placebo-controlled study
involving 200 participants will investigate the impact of the optimal CS dose (amount and duration
determined from the first two aims) for a period of 6 months. Participants will be randomly selected to receive
either the active or the placebo intervention. The CS dose will be measured in the field for all 3 study aims.
The strengths of this project are considerable, as very few instruments are otherwise available to measure
personal circadian light exposures and activity patterns. The study population would benefit immensely and
immediately from a tailored, non-pharmacological treatment to improve sleep efficiency and consolidation.
Effective treatment can significantly reduce the burden on society and, more directly, on caregivers. The expert
project team is unique, including a practicing physician/clinician who has access to the population and a team
of researchers with expertise in lighting, lighting technologies, sleep, and circadian rhythms.

Public health relevance
Project Narrative The progression of Alzheimer's disease (AD) and related dementias (ADRD) leads to abnormal sleep/activity patterns, associated wandering, and disruptive behaviors in AD/ADRD patients, causing tremendous stress and fatigue to family caregivers that can lead to the patients' institutional placement. Our current R01 shows that both short- and long-term light exposures result in significant improvement in sleep, behavior, and mood, but it remains unknown how the light dose (amount and duration) affects circadian response in AD/ADRD patients. Addressing this dose–response issue will further contribute to the scientific understanding of AD/ADRD while providing a translational component for the development of new lighting products designed to promote sleep and reduce behavioral disturbances in AD/ADRD patients.